Minimally Invasive and Versatile Next-Generation Implantable Medical Devices: A Leap Towards Precision Therapies and Medicine

PROJECT SUMMARY
Implantable Medical Devices (IMDs) stand on the brink of a healthcare revolution, providing an unprecedented means of
managing and preventing a myriad of diseases. However, the potential of IMDs is currently impeded by the challenges of
limited interfacing with dispersed neurons, invasive and voluminous designs, and excessive costs, factors that impede their
widespread adoption. This project aims to address these limitations by pioneering a novel generation of IMDs: wireless
microdevices. The proposed devices will be battery-free, injectable microchips capable of deployment anywhere within the
body, integrating energy harvesting, telecommunication functions, and capabilities specific to diverse applications. The
development of the microdevice will necessitate interdisciplinary integration spanning integrated circuits, wireless
powering, materials science, and microfabrication. Key innovations central to this research include the design of compact,
reconfigurable integrated circuits; enhancement of power transfer efficiency; and the application of cost-effective, inkjet
printing-based techniques for efficient device assembly and fabrication. Importantly, this project will introduce for the first
time a precise injection technique designed to enhance placement accuracy and minimize tissue damage. The project's
validation of injectable bioelectric devices in animal models opens avenues for engaging collaboration with neurosurgeons,
neurologists, and industry stakeholders. Together, we envisage translating the technology into clinical trials, implementing
targeted health interventions, and potentially shifting the perception of IMDs from a last-resort solution to an elective option
at earlier disease treatment stages. By developing wireless microdevices that are injectable, scalable, versatile, and fully
addressable, this project represents a technological breakthrough, aiming to redefine the future of implantable medical
devices. This resonates deeply with my career aspiration to be at the forefront of transforming the IMD field.

Public health relevance
PROJECT NARRATIVE This proposed research seeks to develop a new generation of IMDs, termed "wireless microdevices". This will enable the deployment of multiple battery-free, injectable microchips anywhere in the body. These versatile microdevices will integrate energy harvesting, telecommunication functions, and capabilities tailored to specific applications.